Defining the Biology of the ADAR1-RISC Complex

PROJECT SUMMARY
The means by which cells respond to virus infection is critical for survival. Moreover, the cellular response to
virus differs dramatically depending on its position on the tree of life. This observation suggests that there are
many successful strategies to inhibit virus infection, just as there are many viral antagonists that have evolved
to interfere with them. Interestingly, while the cellular response to virus infection in mammals is primarily
mediated by the family of Type I interferons (IFN-I), we recently characterized an IFN-I-independent defense
system that involves an evolutionary conserved RNAse III nuclease. We find that this nuclease, called Drosha,
rapidly translocates to the cytoplasm in response to virus infection and forms a high molecular weight structure
by associating with the RNA-induced silencing complex (RISC) which we have termed the ADAR-RISC Complex
or simply, ARC. Here we seek to better understand the physiological relevance of this complex.

Public health relevance
PROJECT NARRATIVE We propose to characterize the intrinsic antiviral response as it relates to a novel Drosha-containing high molecular weight structure we have termed the ADAR-RISC Complex (ARC). This work will enhance our understanding of virus and host interactions and could significantly advance future therapeutics.